Identification of Anterior Segment Structural Biomarkers in Glaucoma Following Pediatric Cataract Using Ultrasound Biomicroscopy

This K23 application is submitted by Janet L. Alexander, MD, Assistant Professor in Ophthalmology and
Pediatrics. My long-term goal is to become an independent clinical investigator focusing on clinical
applications and innovations in ocular imaging to enhance the care of pediatric patients with ophthalmic
disease. This K23 award will provide the mentored career development needed to gain in-depth expertise in
study design, statistics (culminating in a Master’s of Science in Clinical Research), image analysis (though
coursework and mentorship), and professional development. Glaucoma develops in more than one quarter
of children with congenital cataracts in the 5 years following cataract surgery. Several structural risk factors
for glaucoma following congenital cataract surgery (GFCCS) have been established including age, corneal
size, and anatomic abnormalities of the sclera and ciliary body. Ultrasound biomicroscopy (UBM) has
potential to revolutionize our understanding of these structural risk factors and many more. A critical gap in
the field is our inability to utilize pre-operative data to anticipate GFCCS, to provide accurate personalized
prognosis and earlier diagnosis and treatment. My overall goal is to determine the contribution of structural
anatomy in the risk of GFCCS and offer clinicians a predictive risk profile for GFCCS at the time of cataract
surgery (prior to disease onset) based on anterior segment structural features determined from UBM
images. I hypothesize the structural risk factors (biomarkers) identified in pre-operative UBM images will
reflect structural immaturity and correlate with GFCCS. We will test this hypothesis with the following Aims:
1) We will determine baseline quantitative structural characteristics among healthy subjects age 0-5 years
using UBM images, 2) We will determine structural characteristics among subjects age 0-5 years with
cataracts, to compare the cataract cohort to age-matched controls. The cataract cohort will be followed
longitudinally to determine the structural biomarkers that correlate with development of GFCCS. My training
efforts parallel these Aims and focus on gaining expertise in clinical research, biostatistics, image analysis,
and professional development. In addition to didactic coursework, I will benefit from the close mentorship of
Drs. Steven Bernstein and Bennie Jeng, and established leaders in each area of my intended expertise.
The current study is important because identification of the specific measurable structural risk factors
associated with GFCCS will aid clinicians in diagnosis and provide an immediate high yield potential target
for treatment and prevention. Clinicians will identify structural features from UBM performed prior to cataract
surgery to quantify risk for development of glaucoma. The results of the proposed research will provide the
foundation for a future study examining interventions based on structural biomarkers for GFCCS. The
ultimate goal of my research is to develop quantitative diagnostic tools to enhance clinical care for pediatric
patients with anterior segment disease, leading to improved treatments and reduced childhood blindness.

Public health relevance
Project Narrative This project seeks to identify the structural risk factors for glaucoma following congenital cataract surgery, a devastating adverse event impacting 30% of children after cataract removal. Comprehensive normative anterior segment structural data for infants and children does not currently exist. Ultrasound biomicroscopy image analysis will be used to build a normative baseline anterior segment database for infants and children with and without cataracts, which will be applied to identify structural risk factors or biomarkers for future development of glaucoma, allowing for earlier diagnosis and targeted treatment.